The role of interferon regulatory factors in tanycytes during HFD-induced inflammation, obesity and glucose dysregulation

Project Abstract
The arcuate nucleus-median eminence complex (Arc-ME) is an evolutionarily conserved region
of the hypothalamus that plays important roles in physiology and behavior, including control of
appetite, energy balance, insulin sensitivity, fertility and lactation. In rodent models, the initiation
of a high fat diet (HFD) rapidly induces inflammation specifically within Arc-ME, well in advance
of inflammation observed in peripheral tissues. Genetic studies disrupting this inflammation
protect from obesity, suggesting the inflammation is causal, and studies in humans show a
correlation between arcuate inflammation and obesity. The arcuate has a unique anatomical
relationship with bloodstream, as there is no classic endothelial Blood-Brain-Barrier (BBB)
separating it from the median eminence, which is invaginated by fenestrated capillaries that are
continuous with the peripheral circulation. Here, tanycytes, specialized ependymal cells found
lining the ventricular wall of the basal hypothalamus, extend elaborate processes that separate
the Arc and ME, thereby partitioning the ME, CSF, and brain parenchyma into distinct
compartments. Studies of hypothalamic inflammation have not previously addressed a role for
tanycytes, despite their unique localization. Using single cell RNA-seq, we observe that HFD
induces an interferon response pathway specifically in 2 tanycytes, the subpopulation that
contacts the peripheral circulation. We hypothesize that 2 tanycytes are sentinel cells that
respond to signals associated with HFD by upregulating an inflammatory gene program and
initiates hypothalamic inflammation. We propose to test this hypothesis by examining whether
genetic models in which the interferon response program is specifically induced or disrupted in
tanycytes is sufficient/necessary for induction of hypothalamic inflammation. We further propose
to define specific interferon regulatory factor targets by which tanycytes elicit inflammation using
a combination of transcriptional and epigenomic profiling within tanycytes and estimation of cell-
cell communication from single cell sequencing of our perturbed models. Together, these studies
will demonstrate a new role for tanycytes in initiating HFD-induced hypothalamic inflammation
and identify specific molecular targets that enable them to do so. As 2 tanycytes are located
outside of the BBB, they provide an attractive and specific target cell type modulating energy
homeostasis against which to design therapeutics to combat obesity.

Public health relevance
Project Narrative Obesity related to overnutrition has become a global epidemic that increasingly strains our health care system and has few effective non-surgical therapies. Here, we seek to better understand how high fat diet causes hypothalamic inflammation, one of the earliest pathological responses to overnutrition observed. We focus on the critical role tanycytes, a unique cell type that faces the blood stream on one side and the brain on the other, play in initiating the pathologic response to overnutrition.